A novel approach to ultralong sustained delivery of punicalagin as a potential treatment for osteoarthritis

PROJECT SUMMARY
Osteoarthritis (OA), the gradual erosion of articular cartilage which covers the ends of bones in diathroidial
joints, is a debilitating disease that affects over 32.5 million U.S. adults. There is no cure for OA, and the two
most common intra-articular treatments, corticosteroids and hyaluronic acid, are for pain relief and increased
joint range of motion. Thus, there is an urgent, unmet need for disease-modifying OA drugs (DMOADs) that
would actually inhibit disease progression. Punicalagin (PCG) has been identified as a promising DMOAD
candidate. Our long-term objective is to create a PLGA-based, in situ forming microparticle system capable of
ultralong, intra-articular PCG delivery. We envision semiannual injections that could be given prophylactically
to patients at high risk of developing OA or to slow disease progression in patients with early-stage OA. PCG
is the major polyphenol present in pomegranate. It plays regulatory roles in multiple signaling pathways
involved in the inflammatory process and also inactivates MMP-13, the enzyme primarily responsible for
destruction of cartilage collagen in OA. The approach follows an established workflow for designing an intra-
articular drug delivery system to treat OA, starting with characterization of PCG as a DMOAD, proceeding to
optimization of the delivery system formulation (PCG-containing PLGA solution emulsified into sesame oil),
and then moving to a study of the system’s safety. Specific Aim 1 is to determine the potential for PCG to
inhibit production of IL-1β, TNF-α, and IL-6 (important OA cytokines), as well as MMP-13 and ADAMTS-5 (key
catabolic enzymes in OA) by human chondrocytes, synoviocytes, osteoblasts and macrophages. Cultures
stimulated with the alarmin S100A8 to induce inflammation will be treated with PCG and analyzed two days
later using ELISA. Aim 2 is to optimize emulsion formulation with respect to chondrocyte survival, in vitro PCG
release kinetics, and microparticle size. Variables include PLGA MW, PLGA concentration, solvent, and
polymer:oil ratio, which are expected to influence microparticle size and structure, porosity, and the rate of
solvent diffusion. Some microparticles will be formed in dialysis bags and maintained at 37 °C to monitor drug
release. Additional aliquots of emulsion will be used to assess their cytotoxicity to a chondrocyte cell line and
to characterize the size and morphology of microparticles formed upon injection into water. Specific Aim 3 is to
evaluate the potential for the optimal, drug-free microparticle system to stimulate production of inflammatory
mediators in vitro and to be tolerated in vivo within a joint. Biocompatibility of the optimal emulsion will be
evaluated in cultures of human synoviocytes, chondrocytes, osteoblasts, and macrophages based on
production of proinflammatory cytokines and eicosanoids quantified using multiplex ELISA and LC-MS/MS.
The safety of the emulsion with respect to the intra-articular route of administration will be tested in a rat model.
The proposed research could reveal intra-articularly injected, PCG-releasing in situ forming microparticles as a
new OA therapy capable of drastically decreasing the rate of cartilage degeneration for months at a time.

Public health relevance
Project Narrative The goal of the proposed project is to develop a novel treatment for osteoarthritis based on slow release of a natural pomegranate derivative from polymeric microparticles that is formed upon injection of a polymer-oil emulsion into the knee joint. The treatment is intended to slow the progression of osteoarthritis by suppressing inflammation and thwarting the enzymes that destroy cartilage by inactivating them and decreasing their production. The project involves characterization of the drug’s anti-arthritic effects on human cells, optimization of the microparticle system formulation to achieve prolonged release of drug, and assessment of the drug delivery system’s safety.